Gating of Information Flow Within the Nucleus Accumbens

Stress and the resultant anxiety can provide motivation and prevent reckless behavior. However, when
experience in excess can be deleterious. This is particularly true when stressors occur during the peripubertal
period, when the brain is undergoing substantial plastic changes. In addition, there are significant male/female
differences in experience with stress. Thus, our studies in rats show that, although males and females show
similar impacts of peripubertal stress immediately after the stress, early stress preferentially impacts
cognitive/salience processes in males as adults and postpubertal stress impacting affective behaviors in females
as adults. Our preliminary results suggest that both male and female rats exposed to neurodevelopmental stress
show parvalbumin (PV) neuron loss in the ventral hippocampus (vHipp) leading to a hyperdopaminergic state,
this occurs via different pathways and different periods within puberty depending on sex. Thus, prepubertal
(PreP) stress in males but not females leads to parvalbumin (PV) neuron loss in the basolateral amygdala (BLA)
and mesoassociative striatal dopamine hyperactivity, whereas postpubertal (PostP) stress in females but not
males leads to hyperactivity in the reuniens (RE) nucleus of the thalamus and medial mesolimbic dopamine
overdrive. We propose that this difference is due to a differential impact of medial prefrontal cortical (mPFC)
regulation, with infralimbic PFC (ilPFC) controlling RE activity and prelimbic PFC (plPFC) impacting the BLA.
Thus, our preliminary data suggest that stress has timing- and sex-specific impacts that elicit distinct pathologies
via different circuits in the adult. Our overarching hypothesis is that PreP stress causes males to be selectively
vulnerable to VTA-associative striatal DA hyperactivity in the adult via precocious maturation of the plPFC-
BLA pathway and loss of BLA PV interneurons. In contrast, PostP stress causes selective activation of the
RE, potentially via PV loss in the reticular thalamic nucleus innervated by the ilPFC, in females leading to
hyperactivation of the mesolimbic DA system in adults. We will examine this along three specific aims: 1)
Examine how PreP vs PostP stress impacts the BLA-vHipp projection in male and female rats. 2) Examine how
PreP vs PostP stress impacts the RE-vHipp projection in male and female rats, and 3) Examine how the plPFC
and ilPFC regulate BLA-vHIpp and RE-vHipp response to PreP and PostP stress. This will give substantial insight
into how early stress leads to circuit-wide disruptions that render an individual more susceptible to pathological
states as adults.

Public health relevance
Project Narrative: Although many major psychiatric disorders have their onset in adults, there is increasing evidence that traumatic experiences early in life can predispose an individual to illness as adults. Moreover, males and females show different susceptibilities to pathologies as adults following peripubertal stress. We have found that major stressors delivered to male rats prepubertally versus females postpubertally, while acting similarly soon after the stress, show major differences in the pathways impacted as adults. We propose that this is due to differential regulation by the medial prefrontal cortex. By studying the factors that link differential stress susceptibility to stress-induced damage at the systems level, we hope to better understand why there are substantial differences in susceptibility to adult pathology based on sex, which may lead to more effective means for early intervention that may prevent the emergence of major psychiatric disorders later in life.